Characterization of Fe(II)/alpha-ketoglutarate-dependent hydroxylases

DESCRIPTION (provided by applicant): This project examines the enzymatic mechanism used by FeII/α-ketoglutarate (αKG)-dependent hydroxylases and explores the diversity of reactions they catalyze. Members of this enzyme family are widespread in bacteria and eukaryotes (including humans) where they promote reactions of fundamental importance including DNA/RNA repair, synthesis/degradation of a vast repertoire of small molecules, lipid metabolism, and protein hydroxylation related to oxygen sensing, chromatin demethylation, or structural interactions. The studies detailed in this proposal focus on four aims. First, we will define the chemical steps during early catalysis by applying an innovative continuous- flow Raman spectroscopic approach to TauD, the best studied member of this enzyme family. Of special interest will be the properties of a key TauD variant that slowly forms the known FeIV=O intermediate, as well as the behavior of a thermophilic homologue. Parallel studies will probe for uniformity of the identified reaction intermediates in two other available family members. Second, pulsed EPR techniques will be utilized to investigate the geometries of active site environments for enzymes with bound nitric oxide (NO), a surrogate of O2. Measurements using these novel methods will be validated with TauD, where we have crystallographic information, and then applied to XanA, a xanthine-degrading enzyme, for which structural data are lacking. In particular, these techniques will be exploited to probe small structural changes at the active site upon substrate binding or in selected variant proteins. Third, the presence of a second FeII binding site in TauD will be confirmed and the function of this site will be investigated. As part of these studies, we will explore the use of phosphorescence quenching to obtain thermodynamic binding data on anaerobic proteins. Finally, biochemical and spectroscopic properties will be elucidated for TET1, a 5-meC hydroxylase that might function with another enzyme as a DNA demethylase. In total, this work will enhance our understanding of the enzyme mechanism common to this versatile enzyme family while further defining new and diverse roles for its individual members. Such studies have medical relevance because understanding of this mechanism is critical for developing treatments of human genetic diseases associated with defects in FeII/αKG hydroxylases, for defending against pathogens where such enzymes play essential roles, and for optimizing the synthesis of antibiotics by these enzymes in other microbes. PUBLIC HEALTH RELEVANCE: FeII/α-ketoglutarate dependent hydroxylases catalyze dozens of reactions in humans, and defective enzymes underlie several human genetic diseases. Many pathogens of humans contain key representatives of this enzyme family, and an improved understanding of their catalytic mechanisms will facilitate the development of new drugs for controlling infections. Other microbes use these enzymes to synthesize antibiotics, offering the potential to engineer these catalysts for creating novel antimicrobial agents.

Public health relevance
FeII/α-ketoglutarate dependent hydroxylases catalyze dozens of reactions in humans, and defective enzymes underlie several human genetic diseases. Many pathogens of humans contain key representatives of this enzyme family, and an improved understanding of their catalytic mechanisms will facilitate the development of new drugs for controlling infections. Other microbes use these enzymes to synthesize antibiotics, offering the potential to engineer these catalysts for creating novel antimicrobial agents.